Enhancing Stem Cell Restoration of IOP Homeostasis by Senolytic Treatments

Summary
Glaucoma, a major blinding optic neuropathy, is a progressive, debilitating disease with visual field loss. The
primary risk factor for the disease, as well as the one and only treatable parameter to delay bilateral blindness
and slow the disease is to reduce the elevated intraocular pressure (IOP). The IOP is controlled and adjusted by
the resistance to aqueous humor outflow. This resistance resides within the deepest portion of the trabecular
meshwork (TM), called juxtacanalicular (JCT) region, and in the greater basement membrane of the inner wall
cells of Schlemm's canal endothelium (SCE). IOP changes are sensed by JCT cells as mechanical stretching,
and they react by modifying the outflow resistance to restore the IOP to normal. This is the IOP homeostatic
response. However, this IOP homeostatic response is lost in glaucomatous eyes. In glaucoma there is also
significant TM cell loss. We developed a model for human anterior segment TM cell loss, and in this model, IOP
homeostasis is compromised. Transplanting TM cells, differentiated induced pluripotent stem cells, or human
mesenchymal stem cells in this ex vivo model restores IOP homeostatic regulation.
TM cells become senescent with increased passage in culture or with exposure to H2O2. Aged glaucomatous
TM cells exhibit much higher levels of senescence than normal aged TM cells in tissue. Presumably, these
senescent cells are occupying space in the TM but are not facilitating the IOP homeostatic response or may
even be diminishing it. Transplantation of stem cells into the TM where many senescent cells are present may
diminish how many stem cells can attach and integrate to restore IOP homeostatic function.
Senotherapeutics are recently developed drugs which act upon the senescent cells. Senolytic
pharmaceuticals can selectively clear senescent cells removing them from occupying tissue space or can
reverse some of the negative changes that are characteristic of senescent cells. Senoreverters can reverse the
properties of senescent cells and restore some or complete function. This might include restoration of lost IOP
homeostatic capability. Herein, we propose to use senolytics and separately senoreverters to restore TM cell
IOP homeostatic function to glaucomatous tissue with or without the assistance of stem cell transplantation. This
has the potential to lead to new innovative therapies to restore glaucomatous IOP homeostatic capability.

Public health relevance
Narrative Glaucoma, a major blinding disease controlled by the trabecular meshwork (TM), has sustained intraocular pressure (IOP) elevation as the primary risk factor, with senescent and dead TM cells playing a critical role. Here we will use senolytic drugs and reversal of senescence techniques on senescent cells of human glaucomatous cadaver eyes to facilitate restoration of IOP to normal.